Task C14: Advancing Human Lung Microphysiological Systems to Model Coronavirus Infection and Test Candidate Countermeasures

This contract provides for the development of new and refinement of existing animal replacement and non-traditional animal models and may include evaluation of candidate countermeasures.